Supplement to: Improving the Control of Fear: Healthy Adults to Pathological Anxiety

Abstract attachment not required for PA-16-288.

Public health relevance
Project Narrative (Public Health Relevance Statement) attachment not required for PA-16-288.